Research Training Fellowship in Substance Abuse

Project Summary/Abstract
This is the competitive renewal of a T32 training program, the Research Training Fellowship in Substance
Abuse Program (RTFSA-P), which has been in existence since 1988. Despite recent advances in
understanding the neurobiology of addiction, there is a persistent gap in the application of knowledge gained
from basic science studies to clinical practice in the field of addiction. A new generation of behavioral,
psychopharmacology, neuroimaging, molecular genetics and molecular neuroscience studies has broad
clinical implications and these studies bring the potential to bridge the gap between basic and clinical research.
Despite the quality of the available science, actual progress in bridging this gap depends also upon the
availability of appropriately trained young scientists. The purpose of the RTFSA-P is to meet this need by
providing post-doctoral training for a total of 4 physicians or PhDs interested in careers in translational or
intervention research in the field of addiction. The proposed RTFSA-P is a two-year program in the Division
of Addictions (DA), Department of Psychiatry, Yale School of Medicine, and will afford post-doctoral trainees
the opportunity to devote virtually full-time effort, during the initial phase of their careers, to developing the
skills and experience needed to become independent researchers in the field of clinical or translational
research in substance use disorders. The DA is an ongoing, stable addiction research program that now
encompasses over 123 major funded projects including 4 Centers covering a broad scope of topics and
research methodologies. This facilitates research that moves rapidly and in both directions from preclinical
projects (“bench”) to clinical studies (“bedside” and “community”). Applicants will be MDs or PhD post-doctoral
candidates trained in specialties that include psychiatry, internal medicine, clinical psychology, or
neuroscience. Candidates will be selected by an admission committee based on their potential for excellence
in the field of translational or intervention research in addictions. The RTFSA-P program includes (1)
individualized research preceptorship, (2) successful completion of a translational-research project, (3) a core
curriculum, which includes seminars on addiction clinical research and treatment, biostatistics and research
design, the responsible conduct of scientific research and grant writing skills and (4) individualized participation
in seminars of interest in the Department, Medical School and University. The training facilities include the
major institutions affiliated with Yale School of Medicine, Department of Psychiatry. At the conclusion of
training, applicants will be well suited for independent careers in translational or intervention research in the
field of addiction.

Public health relevance
Project Narrative Clinical and translational research is vital to the development of new treatments for substance use disorders and for understanding the underlying neurobiological causes of these disorders. The Research Training Fellowship in Substance Abuse Program (RTFSA-P) is a well-established program within the Division of Addictions (DA) at the Yale School of Medicine Department of Psychiatry that is dedicated to training young physicians and PhD-level trainees in translational research that spans from basic science studies to clinical neuroscience research related to the field of addictions. The program trains four fellows per year and at the end of training, fellows should be well suited for independent careers in addiction research.